Investigate Host Gene Isoforms Contributing to HIV Persistence in Cocaine Users

PROJECT SUMMARY
Although antiretroviral therapy (ART) is successful to block active replication of HIV, it does not completely
eradicate the infection. HIV remains persistently infected and viral load can rebound after ART withdrawal,
presenting a major obstacle for cure of HIV/AIDS. Investigation of host machineries that regulate HIV replication
will help to improve the understanding of the mechanisms supporting HIV persistent infection. It will also provide
new strategies to perturb host regulatory factors for eliminating residual HIV. This topic is especially relevant for
the HIV-infected drug users, since drug abuse creates a profound impact on HIV infection, increasing the difficulty
to manage HIV viral reservoirs. Our earlier effort includes the identification of novel host restriction factors
specifically associated with a rare subset of HIV-infected individuals (<1%), termed elite controllers (ECs), who
can maintain long-term control over HIV replication in the absence of ART. In a preliminary study, we performed
RNA sequencing analysis and identified alternative splicing variants in cells from ECs, HIV-infected individuals
undergoing suppressive ART, ART-naive HIV-infected individuals, and healthy controls. Differential gene
expression patterns that are specific to ECs and may influence HIV resistance were identified, including
alternative RNA splicing and exon usage variants of the CREM/ICER gene (cAMP-responsive element
modulator/inducible cAMP early repressors). The knockout and knockdown of specific ICER exons resulted in
significantly increased HIV infection. Overexpression of ICER isoforms decreased HIV infection. We also
preliminarily showed that ICER isoforms are dysregulated in cocaine users. Together, these earlier studies
confirm that CREM/ICER is a unique and novel host restriction factor suppressing HIV replication. We propose
to comprehensively investigate their roles in regulating HIV infection, particularly for cocaine users. Furthermore,
we also propose to identify other host gene isoforms that are dysregulated by cocaine use, which overall promote
HIV persistent infection. Our central hypothesis is that certain host genes, including CREM/ICER, undergo
profound RNA splicing to generate distinct isoforms in HIV-infected cocaine users and thus support HIV
persistent infection in this population, which can be targeted to benefit HIV functional cure and mitigate HIV-
induced inflammation. These studies include three related but independent aims. In Aim 1, we will determine
correlations of CREM/ICER, HIV infection, inflammation, and cocaine use parameters. In Aim 2, we will
investigate roles of CREM/ICER in mediating cocaine’s effect on HIV infection and inflammation. In Aim 3, we
will identify novel gene isoforms in CD4+ T cells and monocytes dysregulated by cocaine use.

Public health relevance
PROJECT NARRATIVE Cocaine use is an important topic and is one of the most commonly used drugs in the US, especially in the south, and promotes both initiation and elongation phase of HIV-1 transcription and may affect HIV reservoir activation. Cocaine use is associated with increased inflammation and mortality in antiretroviral treated HIV. This proposal will investigate the mechanisms of host gene isoform expression on functional cure of HIV in cocaine users, which may reveal a novel mechanism on controlling of HIV persistence and help the development of therapeutic strategy for ART-free HIV cure in cocaine users and non-drug users.